The role of IGF-1 signaling in vascular smooth muscle cells in age-related vascular cognitive impairment and dementia

PROJECT SUMMARY/ABSTRACT
Age-related vascular cognitive impairment and dementia (VCID), a subgroup of Alzheimer’s Disease and Related
Dementias (ADRD) is a common cause of disability and reduced quality of life among the elderly. Extensive recent
data have demonstrated that microvascular pathologies in the brain play a central role in these processes. One such
pathology is cerebral microhemorrhages (CMH) which are the result of rupture of small intracerebral blood vessels
and progressively impairs neuronal function. The incidence of CMH dramatically increases with age and hypertension
is one of the major causes for age-related cognitive decline. Yet the underlying cellular mechanisms for CMH and
increased vascular fragility are unknown, and thus therapeutic interventions to mitigate CMH are not available. Blood
vessel integrity requires plasticity of vascular smooth muscle cells (VSMCs), which exhibit an adaptive switch from a
highly contractile to a protective, anti-fragility phenotype in response to stress. Aging fundamentally alters VSMC
phenotypic switching, suppressing the adoption of these protective VSMC features, which are otherwise promoted
by insulin-like growth factor (IGF)-1. Circulating IGF-1 levels are dramatically decreased with age. Low IGF-1 levels
increase the risk for cerebromicrovascular disease and promote the development of CMH in our rodent models,
supporting a role for IGF-1 deficiency in age-related vascular fragility. Our hypothesis is that impaired VSMC
plasticity and function due to IGF-1 deficiency has a fundamental role in increased cerebrovascular fragility and
development of CMH and cognitive decline with age. Aim 1 will test the hypothesis that VSMCs contribute to the
development of VCID/ADRD phenotypes in IGF-1 signaling-deficient models. We will use novel VSMC-specific IGF-
1 receptor knockout lines to probe the role of VSMCs in the development of CMH, impaired myogenic autoregulation
in response to hypertension, and the consequent development of cognitive decline. Aim 2 will determine the
dynamic balance between VSMCs with maladaptive phenotypes and VSMCs with protective phenotypes induced
by age-dependent decrease of IGF1. In this aim we will address the question of VSMC plasticity in vivo,
evaluating both protective and maladaptive VSMC phenotypes in the cerebrovasculature of Igf1r-deficient CMH
models. Aim 3 will evaluate the transcriptional mechanisms governing maladaptive and protective VSMC
phenotypes in regions of vascular fragility/CMH and in surrounding intact vessels. Lineage tracing genetic mouse
models of aging and IGF-1 deficiency, coupled with single-cell RNA-sequencing, will be used to evaluate the
role of novel transcriptional regulators in the adoption of diverse VSMC phenotypes. Pro- and anti-fragility VSMC
phenotypic states will be spatially overlaid with the location of CMH to test the hypothesis that CMH occur
primarily in regions where VSMCs show a maladaptive phenotype. These scientifically and technically innovative
studies will significantly enhance our understanding of the role of IGF-1 deficiency in the development of CMH
and will provide insight into underlying cellular mechanisms which are critical for the development of effective
therapies.

Public health relevance
PROJECT NARRATIVE One of the most common causes of disability during aging is vascular cognitive impairment and dementia (VCID), triggered by cerebral microbleed formation and other microvascular pathologies. The underlying mechanism includes age-related IGF-1 deficiency, which leads to vascular smooth muscle cell dysfunction, increased blood vessel fragility and development of cerebral microhemorrhages (CMH) in the aging brain. CMH can trigger neuroinflammation and consequent neuronal dysfunction, culminating in cognitive impairment and gait disorders, and understanding this sequence of events is critical for the development of effective therapies.